Optimizing Exercise for the Treatment of Anxiety

PROJECT SUMMARY/ABSTRACT
Anxiety disorders are impairing and amongst the most common psychiatric conditions; yet, many
impacted individuals do not receive or respond to evidence-based care. There is thus a great need to develop
and optimize additional first-line, more accessible interventions for anxiety disorders. Exercise has benefits for
anxiety and physical health, without many of the side effects, accessibility issues, or costs of medications or
psychotherapy. However, adherence to exercise recommendations is low, and even worse for high intensity
exercise (HIE) in individuals with anxiety disorders. This may be due to high anxiety sensitivity (AS), or fear of
anxiety-related physiological sensations, as HIE may induce similar sensations. There are, however, no formal
guidelines for optimal intensity or titration of exercise for any mental health condition, and it remains unclear
whether exercise requires slower titration for optimal tolerability and response for anxiety.
In order to develop exercise as a formally prescribed intervention for anxiety disorders in a way that
enhances engagement and adherence, research is needed to guide optimal titration of exercise prescriptions,
and to establish mechanisms that should be targeted to optimize outcomes in practice. Addressing these gaps,
this study will examine the impact of exercise titration on AS/anxiety symptom severity as well as engagement
and adherence. Specifically, 90 sedentary adults with a primary anxiety disorder and moderate to high AS will
be randomized to either 8 weeks of 1) low intensity exercise, or 2) flexible titration to HIE. Blinded, validated
clinician-rated and patient-rated outcomes will be assessed over treatment and at 1- and 3-month follow-up. To
better understand what mechanisms influence decisions to exercise in the real-world, and novel to this
research and key training goals, are the use of heart rate (HR) as an objective mechanistic target for exercise
intensity, examining changes in valuation of exercise through a neuroeconomics task, and the integration of
ecological momentary assessment (EMA) to measure effects of immediate changes in mood with exercise on
anxiety outcomes and adherence. Additional training goals will support the analysis of study data with state-of-
the-art advanced statistical techniques such as growth curve modelling and machine learning.
The scientific aims of this study map onto my training plan in three primary areas: 1) applying an NIMH
experimental therapeutics approach, integrating an objective target mechanism (HR) and transdiagnostic AS,
2) examining EMA data with HR to identify real time drivers of engagement and response outside the office
setting, and 3) applying advanced computational psychiatry techniques to data analysis. Related training goals
will enable integration of neuroeconomic human decision-making models into the current study and integral
training in neural mechanisms of action to support future R-level proposals. Finally, mentorship from Drs.
Simon (primary mentor), Abrantes (Co-mentor), and Glimcher, Jay, Laska, and Pine (advisors) will propel me
toward an independent research career focused on optimizing exercise interventions for mental health.

Public health relevance
PROJECT NARRATIVE Exercise offers great potential as a first-line, formally prescribed intervention for anxiety disorders, but research is needed to improve exercise engagement, establish the optimal titration for exercise prescriptions, and identify which mechanisms to target to optimize outcomes in practice. This Career Development Award project examines a novel exercise titration method as compared to low intensity exercise with objective assessment of heart rate based intensity goals (as target engagement), assessment of real-time changes in mood following exercise (through ecological momentary assessment), neuroeconomic assessment of exercise decision-making, and their association with anxiety and adherence outcomes in sedentary individuals with a primary anxiety disorder and moderate to high anxiety sensitivity. Findings will inform optimal exercise titration methods as well as identify potential mechanisms to support the development of personalized approaches to prescribing exercise as an evidence-based intervention for anxiety.